Hazardous Materials Worker Health and Safety Training Cooperative Agreement ECWTP

NJ/NY Hazardous Materials Worker Training Center
ECWTP Abstract
The NJ/NY Hazardous Materials Worker Training Center has a long history of effective training that meets the requirements
of OSHA 29CFR1910.120, providing hazardous materials knowledge and skills to over 450,000 workers since 1987. Our
Center has effectively trained unemployed and underemployed individuals in job skills and environmental clean-up procedures.
The courses develop competency in workers to critically analyze dangerous situations, and enable them to identify safe work
practices. Key principles of adult education are incorporated into our training, and training courses are developed to include
peer-learning, hands-on activities, and development critical thinking skills. The Center has a robust evaluation plan, and will
continue to expand the types of data collected on the impact of training on workplace practice, as well as how training can
more effectively influence workplace safety culture. Our Center has effectively been able to place our program graduates in
sustainable jobs. Our Center proposes to expand to include Make the Road New York to reach additional target populations.
The ECWTP will utilize focused strategies to recruit, train and employ underserved residents living in disadvantaged
communities for construction and environmental remediation work. The Center has long-term, effective partnerships in
minority and underserved communities that help reinforce occupational health and worker education, and mitigate health
disparities at the community level. Our Center includes training in environmental justice, health and safety, and life skills,
preparing trainees for a career in the environmental industry. Over the next five years, the Center proposes to train 475
students in 290 courses, providing 151,850 contact hours. The program will place at least 80% of graduates in environmental
careers in the construction trades and as Community Health Workers.

Public health relevance
Not Applicable per RFA-ES-19-003